EHR-based Genomic Discovery and Implementation (Bioethics Supplement)

In order to maximize the potential benefits of genomic medicine for all, it is crucial to support the delivery of
genomic medicine in under-studied healthcare settings that serve underrepresented populations. Federally
Qualified Health Centers (FQHCs) provide primary and preventive care to low-income patients in medically
underserved communities. Patients who receive care in FQHCs face various barriers related to the social
determinants of health such as inadequate health insurance coverage, poor access to sub-specialists and
advanced diagnostics, and low health literacy. Healthcare providers working within FQHCs can help bridge the
gap so that advances in genomic medicine reach underserved communities. It remains very uncommon for
genomic medicine services to be offered in FQHCs, despite their potential value to the prevention and
management of chronic diseases that disproportionately impact low-income communities. As a result, there is
a heightened need to capture and conceptualize nuanced, in-depth accounts of healthcare providers’
experiences serving patients in an FQHC, particularly given that the US healthcare system and workforce are
diverse. This project will leverage the infrastructure of the NIH/NHGRI eMERGE IV Network and the parent
eMERGE IV grant to address this gap in promoting health equity in genomic medicine. We propose two aims,
one in bioethics research and one in capacity building in bioethics research. The research aim is to
characterize healthcare provider experiences caring for low-income patients receiving polygenic risk scores
(PRS) in a FQHC in Phoenix, Arizona as part of eMERGE IV. We will focus on the setting, social determinants,
and normative factors that influence how healthcare providers integrate genomic medicine into patient care.
This project utilizes a qualitative, cross-sectional case study of Mountain Park Health Center (MPHC) located
in Phoenix, Arizona, a large FQHC serving low-income minority patients across Phoenix, Arizona. This study
team will conduct semi-structured in-depth interviews with between 15 and 20 healthcare providers working
within MPHC that deliver PRS to patients enrolled in eMERGE IV. Interviews will focus on normative and
contextual factors that impact how healthcare providers experience delivering genomic medical care in the
FQHC setting. The capacity building aim will disseminate our findings with FQHC leaders across the state
through the Arizona Alliance for Community Health Centers in order to generate a conversation on building
capacity for healthcare providers to integrate genomic medicine within under-resourced healthcare settings.
This project aims to advance our understanding of healthcare providers’ experiences as they deliver PRS to
underrepresented populations in an under-resourced healthcare setting, and to disseminate these findings to
stakeholders locally, nationally, and globally. This work is anticipated to inform future genomic medicine
research in FQHCs and other under-resourced healthcare settings while highlighting the value of bioethics
research to improve the translation and implementation of genomic medical care to vulnerable populations.

Public health relevance
Minimizing disparities in the access and uptake of genomic medicine is crucial to maximize its potential. Healthcare providers working in low-income communities face challenges when delivering care in these settings which is made worse when introducing new technologies to their practices. This project will focus on supporting healthcare providers who are using genetic information to improve care of low-income patients.